Tissue-Engineered Models of Lymphatic Drainage in Breast Cancer

PROJECT SUMMARY
Breast cancer is a second leading cause of cancer death in women, exceeded only by lung cancer. Among the
different subtypes, triple-negative breast cancer (TNBC) that does not express the estrogen receptor,
progesterone receptor, and human epidermal growth factor receptor 2, is characterized by poor prognostic
outcomes. TNBC forms solid tumors with high interstitial fluid pressure (IFP). High IFP promotes tumor
progression several ways and cancer immunotherapies are also compromised in TNBC tumors with high IFP
since the interstitial pressure keeps immune cells from infiltrating into tumors. While solid stress formed by fibrotic
tumor extracellular matrix contributes to tumor IFP formation, hyperpermeable blood vessels, combined with
compromised lymphatic drainage, lead to high IFP. To decrease tumor IFP, researchers have tried to reduce
solid stress and normalize leaky blood vessels in tumors. However, how lymphatic drainage is impaired in tumor
microenvironment and how the impaired lymphatic function affects tumor IFP, immune cell interactions, and anti-
tumor immunity are still ambiguous. Several studies have reported that lymphatic vessels (LVs) are structurally
and functionally impaired in tumors, and lymphangiogenic vascular endothelial growth factor C (VEGFC)
treatment inhibited tumor growth by promoting lymphangiogenesis and boosting T cell recruitment to the tumors.
However, VEGFC has also been recognized to promote lymph node metastasis. Given the conflicting effects of
VEGFC, the main goals of this project are to normalize lymphatic drainage in TNBC without using VEGFC or
without promoting lymphangiogensis, by deciphering the mechanisms of lymphatic endothelial cell (LEC) junction
remodeling in TNBC. In this proposal, we will use physiologically responsive in vitro 3D systems of lymphatic
vessels co-cultured with breast cancer cells, which can recapitulate lymphatic structure, lymphatic drainage, and
immune cell interactions in breast cancer. With these organotypic 3D model systems, we will examine lymphatic
junction morphogenesis and drainage in TNBC in the context of a tissue-like and in vivo environment, examine
LEC junction zippering in TNBC-associated LECs, evaluate the roles of lymphatic function in dendritic cell
trafficking to lymphatics, T cell activation, and T cell infiltration in tumors; and assess the roles of LEC junction
zippering for anti-tumor immunity. If successful, our studies will not only identify new targets to treat breast cancer,
but also provide a new tool for mechanism studies and fast screening of potential drug candidates to treat cancer
and lymphatic disease.

Public health relevance
PROJECT NARRATIVE Triple-negative breast cancer (TNBC), characterized by poor prognostic outcomes, forms solid tumors with high interstitial fluid pressure (IFP) in the tumor microenvironment, where the high IFP compromises cancer immunotherapies by limiting T cell infiltration in the tumors. Given that lymphatic vessels are structurally and functionally impaired in TNBC tumors, which can increase tumor IFP and dampen anti-tumor immunity, this project will decipher the mechanisms of alterations of lymphatic structure and drainage in TNBC and examine new strategies to promote TNBC immunotherapies by normalizing tumor lymphatic function.